Pennsylvania: Multi-Site Study of the Health Implications of Exposure to PFAS-Contaminated Drinking Water

PROJECT SUMMARY/ABSTRACT
A former Naval Air Warfare Center in Warminster Township, Bucks County, PA, and the Horsham Air Guard
Station in Horsham Township, Montgomery County, PA, have been found to be the source of widespread
drinking water contamination from per- and polyfluoroalkyl substances (PFAS) that went undetected for
decades. Drinking water contamination was attributed to use of PFAS-containing aqueous film-forming foam
(AFFF), a fire suppressant used in military training exercises. The PA site is characterized by high
magnitude, long duration, and wide-ranging exposure. RTI International, the PA Department of Health
(DOH), Brown University, and Temple University propose to jointly conduct research at the PA site as part of
ATSDR's multisite study. The proposed site is densely populated (>80,000) and has verified perfluorooctane
sulfonate and perfluorooctanoic acid contamination in public water systems (PWS) and private wells. Eligible
adults and children ages 4–17 will have been exposed in the last 15 years. Adults occupationally exposed to
PFAS in chemical manufacture, as a firefighter, or during fire training exercises using AFFF, will be excluded
from the study. Likewise, children whose birth mothers were occupationally exposed will not be eligible. A
two-stage clustered sampling design will be employed, with households selected in the first stage, followed
by the sampling of all adults and children in households. Consistent with findings from a pilot biomonitoring
effort conducted by PA DOH, residences served by PWS closest to the two military bases had higher serum
PFAS levels and will be oversampled. A total of 2,000 adults and 800 children will be recruited for
participation in the study and will complete ATSDR's core protocol, including consenting and interviewing,
anthropometric measurements, neurobehavioral assessments, and biospecimen (blood and urine) collection.
In addition to collecting core data on 2,800 participants, historical water reconstruction of PFAS
concentrations in drinking water around the site will be conducted. Pharmacokinetic modeling will be
conducted to estimate historical serum concentrations of nonoccupational-exposed people. Two investigator-
initiated research activities are also proposed. First, advanced spatial analysis methods will be applied to
model PFAS exposure and other potential cancer determinants over time in relation to a range of cancer
endpoints. Second, exposure estimates will be leveraged to conduct a focused investigation of kidney and
thyroid cancers using a family-based design. The inclusion of the PA site and the investigator-initiated
research proposed in this application will contribute significantly to the scope and rigor of ATSDR's multisite
PFAS environmental health study.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substance (PFAS) exposure through consumer products and drinking water contamination is widespread. Many communities near military and industrial sites have drinking water with much higher PFAS concentrations than EPA's Lifetime Health Advisory of 70 parts per trillion, yet the potential health risks associated with these exposures are not well understood. RTI International, the Pennsylvania Department of Health, Brown University, and Temple University propose to conduct ATSDR's core protocol, and investigator-initiated research that advances PFAS exposure knowledge, at the Horsham Air Guard Station and Former Naval Air Station Joint Reserve Base Willow Grove and Naval Air Warfare Center Warminster site.